Transcriptional regulation of neuronal cell lineage decisions in the developing enteric nervous system

The vertebrate enteric nervous system (ENS), the largest portion of the peripheral nervous system,
mostly derives from the vagal neural crest which arises in the caudal hindbrain, migrates to the foregut
and along the entire length of the gut, differentiating into many different neuronal subtypes. In humans,
defects in ENS formation cause Hirschsprung’s Disease, or colonic agangliogenesis. While ENS neurons play
critical roles in regulating gastrointestinal motility, surprisingly little is known about how or what controls neuronal
lineage specification in the ENS. The recent advent of single-cell technologies promises to help elucidate
identification of neuronal cell types and molecular mechanisms underlying enteric neuronal differentiation.
Zebrafish offer several advantages for tackling important questions in ENS development due to their
simplified enteric nervous system, accessibility to genetic manipulation and facility of imaging. Similar to
amniotes, the zebrafish gut contains neural crest-derived neuronal subtypes, ranging from serotonergic,
cholinergic and dopaminergic neurons to VIP, Substance P and Nitric Oxide (NO)-containing neurons. Here, we
propose to perform single cell RNA-seq of individual enteric precursors and neurons at different developmental
stages (2-6 dpf) within the developing ENS. The function of candidate transcription and signaling factors in ENS
neuronal specification will be tested by CRISPR-Cas9 perturbation experiments in both zebrafish and chick.
Finally, single cell ATAC-seq will be used to identify and then dissect enteric enhancers to build an ENS gene
regulatory network. We propose to perform the following aims:
Aim 1: Transcriptional profiling of the enteric neural crest-derived cells at individual cell resolution using
single cell RNA-seq and multiplex fluorescent in situ hybridization. We will perform single cell RNA-seq on
thousands of cells per time point (2-6 days post-fertilization) of enteric precursors and neurons dissected and
sorted from the zebrafish embryonic gut. We will validate expression of genes of interest, in particular
transcription factors and signaling molecules, using hybridization chain reaction (HCR) and infer developmental
trajectories from progenitor to neuronal differentiation.
Aim 2: Role of transcription factors in differentiation of ENS neuronal subtypes in zebrafish and chick.
We will mine the scRNA-seq to identify transcription factors whose expression correlates with the progenitor
state (e.g. hey1a) and various neuronal subtype markers (e.g. ebf1a, etv1, Klf6a, Insm1a) for functional validation
using CRISPR-Cas9 mediated knock-out in zebrafish and in chick.
Aim 3: Identifying active enhancers associated with neuronal differentiation in the ENS using single cell
ATAC-seq. We will use single cell ATAC-seq to identify and test putative regulatory elements functioning in
neuronal precursor and differentiating neurons in the developing zebrafish ENS. Putative enhancing regions will
be tested for their ability to drive ENS expression in zebrafish, mutated and tested for conservation with amniotes.

Public health relevance
Public Health Relevance Statement The enteric nervous system (ENS) is a critical part of the peripheral nervous system that controls gut motility and other functions. Abnormal development of ENS leads to life threatening disorders like Hirschsprung’s disease. Our results will provide important clues regarding mistakes that may lead to birth defects in the ENS.